Solutions for Organizing, Sharing and Making Discoveries from iEEG Data

Project Summary/Abstract
Direct recording of neural activity from the human brain using implanted electrodes (intracranial EEG,
iEEG) is a fast-growing and high-impact technique in human neuroscience. The NIH has mandated data
sharing plans, but useful sharing that promotes neuroscience discoveries from archival datasets faces many
obstacles. One obstacle is difficulties in creating shareable iEEG datasets. In Aim 1, we will create new tools
based on the iEEG-BIDS standard, created in 2019 to promote sharing by providing specifications for iEEG
datasets. Aim 1A will create an iEEG-BIDS compliant solution for anatomical iEEG data, localizing electrodes
using the pre-operative MRI and post-operative CT scans. Aim 1B will create an iEEG-BIDS compliant solution
for functional iEEG data, the voltage by time data collected from each electrode as a measure of neural activity.
Aim 2 will address the problem that it is currently very difficult for iEEG investigators to share the results of
their iEEG analyses, and difficult for other scientists to explore them. A new tool will merge an advanced 3D
Viewer designed for iEEG with the output of an investigator's existing anatomical and functional iEEG
pipelines. The tool will export a single, compact package that can be shared directly with other scientists or
uploaded to journals or an archive. By simply opening the package in a web browser, users will be able to
interactively explore the dataset, facilitating replication, reliability, and new discoveries.

Public health relevance
Project Narrative Direct recording of neural activity from the human brain using implanted electrodes (intracranial EEG, iEEG) is a fast-growing and high-impact technique in human neuroscience. The NIH has mandated data sharing plans for all investigators and funded the creation of open archives for iEEG data, but sharing faces many obstacles. We will remove these obstacles by creating new tools for organizing, sharing and making discoveries from iEEG Data.